Determining the mechanisms of Toxoplasma gondii colonization and crossing of the placental barrier

PROJECT SUMMARY
Our understanding of Toxoplasma gondii (T. gondii) and other pathogens transmitted from mother to fetus is
limited. However, they significantly contribute to fetal illness and death worldwide. This proposal aims to
address this knowledge gap by identifying and characterizing T. gondii proteins that play a role in crossing the
placenta and causing congenital infection. The research team will use innovative methods and tools, such as
the similarity of the guinea pig placenta to humans and a new in vitro placental barrier derived from human
trophoblast stem cells, to study the role of a particular T. gondii protein, TgMIF, in the parasite's ability to cross
the placental barrier. They also aim to identify new parasitic proteins that might contribute to vertical
transmission. Preliminary data suggests that only a fraction of extracellular parasites can cross the trophoblast
barrier in a manner dependent on a host intercellular adhesion protein called ICAM-1. Furthermore, it has been
found that recombinant TgMIF alone can increase ICAM-1 levels on trophoblasts, which might enhance the
parasites' ability to cross the placental barrier and infect the fetus. The study's first Aim is to test the hypothesis
that TgMIF mediates extracellular parasites to cross the trophoblast barrier and/or T. gondii replication in these
cells, using in vitro placental barrier and pregnant guinea pig models. The researchers expect to determine
whether both phenomena are involved in fetal infection and pinpoint the role of TgMIF. In the second Aim, the
researchers will test the hypothesis that unknown parasitic plasma membrane proteins interact with the host
cell protein ICAM-1 and enhance the ability of extracellular parasites to cross the trophoblast barrier. They plan
to use a CRISPR/Cas9 loss-of-function screen with the trophoblast barrier to identify these new parasitic
proteins. In conclusion, the research team will use stem cells, animal models, genetic tools, and high-
throughput screens to achieve the goals of this R21 application. The results of this proposal are expected to
identify and characterize crucial proteins that mediate T. gondii vertical transmission and establish a scientific
basis for developing therapies to prevent fetal infection.

Public health relevance
PROJECT NARRATIVE We still have limited knowledge about how some pathogens, such as the eukaryotic parasite Toxoplasma gondii (T. gondii), are vertically transmitted from the mother, causing fetal malformations and death worldwide. We use a new in vitro placental barrier and pregnant guinea pig models to describe the role of T. gondii protein TgMIF in vertical transmission and aim to identify novel parasitic effectors enhancing T. gondii's capacity to cross the placental barrier. These discoveries will offer insights into the mechanistic aspects of T. gondii vertical transmission and potentially lead to the development of new therapeutics protecting the fetus from infections.